Mouse Core

The overall objective of this core is to generate, breed, genotype and provide genetically modified mice to investigators of the NWRCE. The unique resources developed and managed by this core and the increased needs and anticipated utilization of these resources motivated the creation of a separate transgenic mouse core for this competitive renewal. The Specific Aims of this core are: Aim 1) Advise investigators of the RCE on appropriate use of mouse models for their studies. Aim 2) Breeding, husbandry, and genotyping of existing mutant mouse lines and generation of new compound genetic mutants through intercrossing and genotyping of existing mutant mouse lines. Aim 3) Generation of new genetically modified mice. Aim 4) Rapid generation of congenic mice from mice on mixed genetic backgrounds using a 'speed congenics'approach.

Public health relevance
Mice - particularly genetically modified mice - are a crucial resource by which to study the pathogenesis of infectious diseases, including those caused by the Gram-negative bacterial pathogens that are the focus of this RCE. Mouse models also allow us to evaluate the effects of therapeutic or prophylactic interventions. Moreover, through the creation of 'humanized mice' and mice harboring common variations of human genes that may affect their response to such infections or interventions, it is possible to refine these models to better emulate humans.